DF/HCC Kidney Cancer SPORE Administrative Core

Summary
The purpose of the Administration, Evaluation and Planning (Administrative) Core is to assure the
coordination of the Dana Farber/Harvard Cancer Center (DF/HCC) Kidney Cancer SPORE components and
to continue to provide oversight and leadership for the scientific, administrative and fiscal aspects of the
SPORE. The Administrative Core allows for the provision of stimulating intellectual activities, organization of
venues for planning future research through seminars and retreats, and the oversight of research and
spending. Drs. McDermott and Kaelin, the SPORE Directors, are committed to the success of the SPORE
and will personally monitor the progress of the Projects and Cores, oversee the Career Development and
Developmental Research Programs, and oversee all other proposed activities. As both SPORE Directors
and Leaders of the Kidney Cancer Program within the Dana-Farber/Harvard Center (DF/HCC), Drs.
McDermott and Kaelin have the authority and resources to ensure the success of this SPORE. The
Administrative Core of the DF/HCC Kidney Cancer SPORE will accomplish the goals of the SPORE by
following six specific aims: 1) Monitor research progress and plan for the future, 2) foster collaborative
research within and between SPOREs, 3) Integrate the DF/HCC Kidney Cancer SPORE into the structure
of DF/HCC, 4) Provide necessary resources and fiscal oversight, 5) promote patient participation,
particularly minorities, in Kidney Cancer research and treatment 6) Promote rapid dissemination of
significant research findings and free and open communication and resource exchange between the
DF/HCC SPORE and other institutions. As they have since early 2014, Drs. McDermott and Kaelin will
provide the tools to foster collaborations between the institutions inside and outside of the SPORE, to
leverage the considerable power of the SPORE in order to promote kidney cancer research.

Public health relevance
Narrative: The Administrative Core has been vital to the successful function of the SPORE. It has handled the scientific, administrative and fiscal responsibilities of the SPORE, maintained the expanded communication and educational efforts of the Program with newsletters and conferences and fostered additional research collaborations both within and outside DF/HCC. It has carried out an annual review of SPORE Projects and Cores, directed the selection of Career Enhancement Program Awardees and Developmental Research Projects and shepherded a thorough selection process for new Projects to be included within the initial SPORE competitive renewal and this competitive renewal application.